Expanded Occupational Health Surveillance in Massachusetts

The Massachusetts Department of Public Health’s Occupational Health Surveillance
Program (OHSP) is proposing to build on its extensive experience and network of partners to
continue and enhance the Expanded Program for occupational health surveillance and
prevention. The overarching aim of the program is to reduce the incidence and severity of work-
related injuries and illnesses and improve worker health in Massachusetts. This proposal has
strong support from state agency leadership and has leveraged additional state and federal
resources to supplement its core surveillance funding.
Work-related injuries and illnesses are preventable. While Massachusetts has made
progress in improving worker health and safety, work-related injuries and illnesses remain a
significant public health threat. One to two workers are fatally injured each week in
Massachusetts. For every fatality, there are an estimated 890 nonfatal injuries and illnesses
reported by employers, amounting to over 86,000 work-related injuries and illnesses per year.
Previous studies have demonstrated that the true number is much higher. As has been
demonstrated recently with COVID-19, this burden falls disproportionately on low wage workers,
primarily immigrants and workers of color, who are often employed in more dangerous jobs.
Work-related injuries and illnesses have serious health and economic costs for workers, their
family, employers, and society. While the full costs in Massachusetts have not been calculated,
over $1.26 billion dollars were paid in Massachusetts Workers’ Compensation benefits in 2018.
The purpose of this proposal is to continue and enhance OHSP’s Fundamental Project
and three of its currently funded Expanded Projects to meet the identified needs of the state.
OHSP proposes broadening the scope of the Fundamental Project to provide more cross-
project coordination and intra-departmental collaboration on complex evolving issues, such as
COVID-19 and health equity. The proposal builds on our commitment to underserved workers
by using a health equity framework to guide our work. This proposal will expand OHSP’s ability
to use health informatics and to collaborate with partners in order to identify and respond to
unsafe work conditions and ameliorate their impact on the health and quality of life of workers.
OHSP proposes to continue and enhance its three Expanded Projects on worker fatalities,
health care workers, and work-related respiratory diseases. Ultimately, the proposed Expanded
Program will lead to reductions in hazards in MA workplaces, improved worker health, and lower
costs.

Public health relevance
The Massachusetts Department of Public Health’s Occupational Health Surveillance Program (OHSP) is proposing to build on its extensive experience and network of partners to continue and enhance its Expanded Program for occupational health surveillance and prevention. The proposal contains focused surveillance and intervention systems for priority occupational health conditions and populations, collaborations with government and community partners to address identified problems, broad-based prevention activities based on surveillance findings, and integration of occupational health into mainstream public health practice. This proposal will contribute to foundational knowledge about the prevention and reduction of work- related injuries and illnesses using state occupational health surveillance programs.